In-Vivo Patient-Specific Optimization of Transcatheter-Edge-to-Edge Repair in Mitral Regurgitation

PROJECT SUMMARY
Mitral regurgitation (MR) is a prevalent and deadly disease characterized by the inability of the mitral
valve (MV) leaflets to coapt properly, permitting backflow of blood from the left ventricle into the left
atrium. The etiologies of MR are complex and diverse, ranging from myxomatous degeneration of the
valvular tissue to myocardial infarction to non-ischemic cardiomyopathy. Several types of treatment are
available, but the efficacy of these interventions remains suboptimal and unpredictable. One of these
options is the relatively recent transcatheter edge-to-edge leaflet clipping technique called the MitraClip
procedure (or TEER). Though the procedure is safe, its outcomes in clinical trials, particularly compared
to other surgical and therapeutic treatments, have been highly contradictory, largely due to the
multifactorial nature of MR. Therefore, it is clear that a predictive approach to treatment selection that
accounts for patient specific variations in MV shape and deformation is necessary to optimize long-
term patient outcomes. Our group has developed a noninvasive, image-based method for in vivo MV
strain estimation which allows us to quantify MV shape and deformation directly from clinically available
imaging data. We have also previously demonstrated that this technique can be used to identify
predictive, presurgical factors of repair efficacy for ischemic MR patients undergoing undersized ring
annuloplasty. However, previous work by our lab and others has focused on limited subsets of MR
patients; in order to develop a comprehensive treatment selection guide, simulations must be grounded
in a robust understanding of the altered MV biomechanical state in the full range of MR etiologies.
Furthermore, the effects of the highly non-physiological focal stress of the MitraClip on the immediate
and long-term shape and deformation of the MV leaflets remains almost completely unknown. We will
additionally develop a fully predictive finite element simulation of the TEER procedure in order to
preoperatively test various MitraClip scenarios directly on a 3D model of the patient's MV apparatus,
use our understanding of the MV functional state to predict the 12-month outcomes of each
configuration, and select the most optimal option. Therefore, in this study, we aim to (1) establish the
pre-operative state of the MV across the MR spectrum and (2) elucidate and predict the consequences
of the MitraClip on MV leaflet geometry, behavior, and remodeling in order to explain and ultimately
predict the outcomes of this treatment in a patient-specific and quantitative manner.

Public health relevance
PROJECT NARRATIVE Mitral regurgitation is the backward leakage of blood towards the lungs when the heart contracts, often as a consequence of heart attacks or degeneration of the mitral valve tissue. Current surgical repair techniques for mitral regurgitation have alarmingly high rates of long-term regurgitation recurrence, and clinical trials studying transcatheter edge-to-edge repair have reported highly contradictory outcomes, largely due to the widespread variation in patients' preoperative clinical characteristics. Our objective is to understand how the mitral regurgitation disease process and transcatheter repair alter the mitral valve's geometry and function, and to preoperatively simulate transcatheter repair directly on a 3D model of the patient's mitral valve to predict long-term recurrence and select the best method of repair to improve the patient's long-term outcomes.